The Functional Interplay Between Phase Separation, Fibrillization, and Posttranslational Modifications of ALIX

Project Summary.
Human ALIX (also known as PDCD6IP) functions in endo-lysosomal pathway, apoptosis, enveloped virus budding, and
other essential cell signaling and membrane scission processes. These diverse functions are regulated by its posttranslational
modifications (PTMs), specifically tyrosine phosphorylation and ubiquitination. We recently uncovered that ALIX, through
its proline-rich domain (PRD), forms liquid-like condensates and amyloid fibrils, and that both these assemblies dissolve
on phosphorylation and reform on dephosphorylation of its tyrosine residues. Projects in this ESI-MIRA proposal expand
upon these exciting discoveries and will uncover the dynamic functional interplay between phase separation, fibrillization,
and PTMs of ALIX. Specifically, we will: determine the structural characteristics of ALIX’s assemblies, their regulation by
tyrosine de/phosphorylation and membranes, and their formation in mammalian cells (direction 1), elucidate the functional
relevance of ALIX polymerization, and the mechanisms of the time-dependent transitions of ALIX condensates to fibrils
(direction 2), and characterize the interactions between ALIX and ubiquitin, and determine the cross-talk between ALIX
ubiquitination and its phosphorylation-mediated polymerization (direction 3). Structural characterization of ALIX’s higher-
order assemblies in direction 1.1 will reveal the interactions hotspots that govern its phase separation and novel atomic-
resolution details of how a PRD can form β-sheet rich fibrils. Mechanistic studies in direction 1.2 will elucidate regulation
and modulation of ALIX condensates and fibrils by lipid membranes and tyrosine de/phosphorylation, revealing how a
kinase accesses its sites within these assemblies, and the identity of tyrosine residues whose dephosphorylation triggers
ALIX polymerization. Cellular studies in direction 1.3 will examine ALIX polymerization in mammalian cells. In direction
2.1, we will determine how polymerization affects ALIX’s functions. Mechanistic studies in direction 2.2 will elucidate
time-dependent hardening of ALIX condensates into fibrils, yielding new insights into the role of phase separation in
fibrillization. Structural and kinetic studies in direction 3.1 will elucidate the interactions between ALIX and ubiquitin.
Finally, in direction 3.2, we will determine the impact of ALIX ubiquitination on its phosphorylation-mediated
polymerization. The above studies build upon our discoveries of the unique ALIX assemblies, their modulation by PTMs,
the slow maturation of ALIX condensates into rigid fibrils, residue-specific details of ALIX – late endosomal membrane
interactions, and how ALIX’s phosphorylation inhibits these interactions. Extensive preliminary results, including highly
homogenous samples of ALIX assemblies enabling their structural characterization, the discoveries of selective recruitment
of ALIX’s signaling partners in its condensates, and of ALIX – ubiquitin interactions in solution, assure high feasibility of
successfully completing our proposed studies. Our newly developed methods, including a new labeling strategy to facilitate
NMR studies of ALIX assemblies, and the production of milligram quantities of pure ubiquitinated proteins, promise
groundbreaking insights into ALIX polymerization and the role of ubiquitin in ALIX biology. Collectively, these studies
will define molecular mechanisms that underlie ALIX’s multifaceted cellular and membrane functions.

Public health relevance
Project Narrative. Human ALIX is involved in many essential cellular and membrane scission processes. This proposal aims to understand in molecular detail the interdependence between ALIX polymerization, its posttranslational modifications, including tyrosine phosphorylation and ubiquitination, and its cellular and membrane functions.